Dynamic switching in the brainstem: a spatiotemporal mechanism for the neural control of breathing

PROJECT SUMMARY
Breathing is necessary for survival, and failure to breath results in death. Simultaneously, the precise and flexible
control of breathing is crucial for maintaining homeostasis (e.g., blood oxygenation during exertion), and to serve
higher order functions such as vocalization. The neural control for both the inexorable and the flexible capabilities
of breathing arises from the activity of neurons in the brainstem. The intrinsically rhythmic pre-Bötzinger complex
(preBötC) is thought to be the core or “kernel” driving rhythm generation, but a distributed network of neural
centers that extend rostrally and caudally from the preBötC, known as the Ventral Respiratory Column (VRC),
has been implicated in control of varied aspects of respiration (e.g., inspiration, expiration, sighing, gasping).
Lesion experiments and isolated recordings from in-vitro brain slices have given insights into the roles of the
different sub-nuclei that govern respiration. However, it remains unknown how the activity of these neuronal
populations is dynamically coordinated to adjust respiratory behaviors during normal breathing and gasping.
Here, we record simultaneously from large, spatially distributed populations of genetically identified single
neurons across the VRC in-vitro and in-vivo. Based on our preliminary data, we propose a novel “dynamic
switching” hypothesis: coordinated neural networks recruit discrete, but anatomically overlapping, populations of
neurons to drive unique respiratory behaviors. Moreover, the respiratory role (e.g. inspiratory/expiratory) of
individual neurons is not static, as is currently thought, but dynamic and changes with respiratory behavior. This
hypothesis is analogous to phenomena observed in locomotor gaits in which discrete spatiotemporal muscle
patterns give rise to discrete modes of movement (e.g. walking, trotting, galloping). This proposal tests the
dynamic switching hypothesis through three specific aims: Aim 1 quantifies the dynamic and coordinated
respiratory roles of single neurons in in-vitro brain slices and in-vivo in anesthetized, breathing mice. We employ
state-of-the-art high-density electrophysiology (Neuropixels) with optogenetic techniques to identify the
functional role and genetic identity of hundreds of simultaneously recorded neurons and compare the
coordinated activity of these populations both between in-vitro and in-vivo preparations. Aim 2 describes how
these dynamic networks reconfigure during gasping. Lastly, in Aim 3 we corroborate results in freely behaving
animals where respiratory behaviors are highly flexible (e.g. sniffing) and are modulated by top-down centers.

Public health relevance
PROJECT NARRATIVE Breathing is a critical physiological behavior that supports life from our first moment to our last. Anatomically and genetically diverse populations of neurons in the brainstem are responsible for both the effortless persistence of breathing from birth to death, and the flexible control that allows for complex behaviors like feeding and vocalizing. This project utilizes novel experimental techniques to unravel how neural populations distributed throughout the brainstem work together and how they are reconfigured to control different breathing frequencies and gasping.